DC CFAR Administrative Core

PROJECT SUMMARY
This goal of this proposal is to revise the District of Columbia Center for AIDS Research (DC CFAR)
Administrative Core to include the CFAR Pathway Programs Coordinating Center (CPPCC). The CPPCC will
include three Cores:
The Administrative Core will be led by the DC CFAR Director Dr. Alan Greenberg and Administrative Director
Ms. Brandi Robinson. The CPPCC will be responsible for fiscal oversight of CPPCC resources, maintenance of
the CPPCC website, developing and disseminating the quarterly CPPCC e-newsletter, and coordinating cross-
CFAR scientific publication efforts. The Administrative Core will schedule quarterly meetings with the CFAR
pathway program leads and with the NIH CFAR Program Office.
The Program Core will be led by Dr. Anthony Wutoh, Howard University Provost and DC CFAR Developmental
Core Co-Director, and Dr. Lisa Bowleg, DC CFAR Social and Behavioral Science Core Co-Director. The
Program Core will convene quarterly meetings of the CFAR pathway program leads which will be the principal
forum for exchanging programmatic ideas, identifying best practices and common challenges, and providing
high-level feedback to the NIH. The Program Core will also develop cross-CFAR activities such as facilitating
access to didactic sessions across CFAR sites, cross-CFAR exchange of information about mentored research
experiences, and national meetings of CDEIPI scholars and mentors.
The Evaluation Core will be led by the DC CFAR Co-Director Dr. Manya Magnus and Senior Research
Program Manager Ms. Lorena Segarra. The Evaluation Core will convene quarterly meetings of the CFAR
pathway program evaluation leads to coordinate the monitoring and evaluation components of CFAR pathway
programs; chronicle the development of the program approaches; develop, harmonize, and assess short- and
long-term process and outcome measures; and conduct qualitative and quantitative research about the overall
delivery and impacts of the program. The three primary activities will be building and implementing a
consensus-based evaluation strategy with CFAR pathway programs; collecting, managing and analyzing
individual- and aggregate-level characteristics to inform our understanding of the challenges and successes
encountered by newly and previously funded CFAR pathway programs; and leading innovative approaches to
describe the impact of the CFAR pathway programs.